Tracing and Controlling Fates of Single Host Cells during HIV Infection

Project Summary/Abstract
Human Immunodeficiency Virus 1 (HIV-1) infection outcome is variable between single host cells, even within
clonal populations. Host factors are variably expressed and can promote susceptibility to infection and latency,
a state wherein a copy of the virus remains in the host genome, posing a serious therapeutic challenge. Yet, no
lasting solutions to these problems exist to date because we lack a comprehensive knowledge of the drivers of
host cell state to distinct infection fates. Targeting the source of single cell variability in HIV-1 infection may
provide strategies for its prevention, treatment, and cure. My proposed work will investigate how certain cell
states permit HIV-1 infection and latency—two major roadblocks to lasting cures. Here, I propose to 1)
nominate host cell state drivers of HIV-1 susceptibility, and 2) redefine HIV-1 infection at the single-cell level
using a new viral isoform capture method. Toward this end, I will develop preVIEU, a multimodal framework
combining DNA barcoding, single-cell profiling, viral mRNA isoform capture, and computation. To determine
the extent HIV-1 infection fate is predestined by cell state, I will barcode primary CD4+ T cells and track if “twin”
sibling cells share the same fate upon HIV-1 challenge. To then reveal what specific state predetermines a cell
to either active or latent infection, I will profile cells using CITE-seq—combined single cell transcriptomic and
protein abundance measurement—and link one sibling’s initial state before viral exposure to the other sibling’s
infection fate via their shared barcode. I will experimentally validate that these states drive a specific fate, and
screen for proteins and pathways underpinning these states to identify factors controlling infection outcomes.
To better understand infection dynamics within single cells, I will develop the viral isoform capture component
of preVIEU that I will then apply to study cell-, cell type-, and tissue-specific infection states in SIV-infected,
ART-suppressed macaque samples. Lastly, I will monitor latency reversal in single cells to determine
synergistic drug treatments to improve the targeting of the latent reservoir. Overall, I will develop generalizable
frameworks to infer host cell infection state-to-fate mappings at unprecedented resolution to further our
understanding of HIV-1 infection dynamics and pave the way for precise disease control strategies.

Public health relevance
Project Narrative Variability of single cells is known to drive response to stimulus across biological contexts, but how single host cell variability determines the outcome of HIV-1 infection is unknown. Understanding HIV-1 establishment, replication, and latency in single cells requires overcoming technological gaps. The proposed work will develop novel tools to connect initial cell state to eventual fate in single host cells, and demonstrate that these states may be manipulated to control the course of infection.